Developing, Validating, and Implementing an Epidemiological Instrument to Assess the Effect of Resistance Training on Measures of Cardiometabolic Disease

A. PROJECT SUMMARY
Skeletal muscle is the most abundant insulin-sensitive tissue in the body making it an important organ system
in the prevention of cardiometabolic disease. Resistance training is the physical activity modality that directly
increases muscle hypertrophy and in doing so increases GLUT4 expression. GLUT4 is an insulin-regulated
glucose transporter with the primary role of stimulating glucose uptake; therefore, hypertrophy leads to
increased insulin sensitivity. Resistance training and enhanced insulin sensitivity have the potential to lower the
burden of cardiovascular and metabolic disease. However, what we know about the role of resistance training on
long-term health outcomes is limited by the blunt tools currently used to measure resistance training in
longitudinal epidemiologic studies. Progress in the physical activity epidemiology field is limited because
resistance training volume is not measured in population studies with the same level of precision as aerobic
activity and as a result, we do not know the optimal balance of movements to promote health across the life
course. The objective of the proposed research is to ameliorate the gap in assessing resistance training volume at
an epidemiological level and assess how resistance training volume affects cardiovascular and metabolic disease
independently and jointly with aerobic activity. The training will enable the scientific objectives of this
application, which are to evaluate the independent and joint associations of resistance training with estimates of
insulin resistance and blood pressure. This award will provide Dr. Booker with added training in 1) survey
development, 2) resistance training, 3) cohort development, and 4) biostatistics. Training will take place at
Northwestern University Feinberg School of Medicine, supported by a strong team of mentors from multiple
peer institutions with expertise in each of these areas. In the K99 phase, Dr. Booker will develop and validate an
epidemiological instrument to collect resistance training volume (Aim 1) and identify the age group where the
instrument performs the best. During the R00 phase, Dr. Booker will use the instrument to determine the
association of resistance training volume with estimates of insulin resistance and blood pressure (Aim 2). He will
then determine the optimal ratio of movement behaviors for estimates of insulin resistance and blood pressure
(Aim 3). The proposed training and research will propel Dr. Booker towards successfully achieving his long-term
research goal of developing tailored physical activity training programs to promote ideal cardiovascular and
metabolic health. Resistance training has emerged among the top fitness trends worldwide and has the potential
to serve as another tool to lower the burden of cardiovascular and metabolic diseases.

Public health relevance
B. PROJECT NARRATIVE Resistance training is a popular exercise modality for individuals across the lifespan and of all body types; however, the role of resistance training on measures of cardiovascular and metabolic disease is not known. This research will 1) develop and validate an epidemiological instrument to collect resistance training volume, 2) assess the effect of resistance training volume on estimates of insulin resistance and blood pressure, and 3) determine the optimal ratios for physical activity for improved estimates of insulin resistance and blood pressure. This research has to potential to inform future tailored intervention studies to target specific measures of cardiovascular and metabolic disease.